Core 1: Administration (251-266)

This core is designed to provide administrative oversight for the entire center and to: 1) Set the Center's overall arching goals;evaluate and ensure progress towards those goals through monthly meetings of the steering committee (consisting of project and core Principal Investigators), yearly evaluation meetings by the center membership, and a yearly meeting with the internal and external advisory boards 2) Coordinate the scientific projects through the steering committee, monthly colloquia with internal speakers, monthly colloquia with external speakers, a center wiki and website 3) Oversee the training of interdisciplinary researchers at the undergraduate, graduate, post-doctoral, and junior faculty levels as well as training in interdisciplinary project administration, which will occur through faculty mentor-mentee relationships, dual-faculty mentoring of graduate students, twice yearly professional development sessions for post-doctoral research associates and graduate students 4) Expand knowledge about executive function among center researchers through colloquia, a website and wiki, and a yearly scientific conference 5) Coordinate outreach to scientists via our website, colloquia, yearly conference and data sharing;clinicianresearchers via a half day conference;clinicians via in-service presentations;and the public via our website and an Open House 6) Disseminate the results of the center's work through scientific and lay publications, through conference presentations, and through our website and other outreach activities 7) Provide fiscal management for the center, and 8) Oversee data sharing according to NIH guidelines